EFFECTS OF AGE ON HYPOTHALAMIC/PITUITARY/OVARIAN ACTIVITY IN NORMAL WOMEN

This study will seek to determine the effects of age on reproductive function in women during the earlier and later reproductive years, during the perimenopause, and after menopause. Recruitment continuing.